Multi-ethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC): Expanding Recruitment to Adults Aged 65 and Older

Project Summary
Older adults of Asian American (AsA), Native Hawaiian, and Pacific Islander (NHPI) backgrounds represent
one of the fastest growing demographics in the U.S. However, factors associated with healthy aging in these
populations, including physical and cognitive function, as well as cardiometabolic diseases and other chronic
conditions, remain poorly understood. This knowledge gap stems largely from their underrepresentation in
biomedical research. To address this disparity and develop a more comprehensive understanding of health
across the lifespan in AsA and NHPI populations, we propose expanding the Multiethnic Observational Study
in American Asian and Pacific Islander Communities (MOSAAIC) cohort to include participants aged 65 and
older. MOSAAIC is an NHLBI-funded newly established prospective cohort study, which will recruit 10,000
AsA-NHPI adults aged 18 to 64 from five U.S. Clinical/Community Field Centers (CCFCs) with the goal to
study a wide range of health outcomes including cardiometabolic, pulmonary, and mental health conditions,
and risk factors such as culture, indigeneity, diet, health behaviors, acculturation and social drivers of health
(SDOH). MOSAAIC is currently in its pilot phase with a full-scale launch of participant recruitment planned for
August 2025. This expansion is thus both timely and efficient. It will leverage MOSAAIC’s existing
infrastructure for organization, data management, and biorepository capabilities, along with the scientific,
statistical, and culture expertise of our exceptional team. Recruitment will draw upon our strong community
partnerships and employ our culturally tailored data collection tools, which have been translated into five Asian-
language versions and refined through extensive feasibility studies conducted earlier in 2024. The proposed
expansion has three specific aims. Aim 1 is to expand the cohort by recruiting 1,500 participants aged 65 and
older from East, Southeast, and South AsA, NH, and PI communities across the U.S. through five
geographically diverse CCFCs. Aim 2 is to implement the MOSAAIC core protocol, which evaluates
cardiometabolic and pulmonary outcomes, as well as SDOH and demographic, cultural, behavioral, and
biological factors that may influence these outcomes. Aim 3 is to expand the assessment of aging-related
health factors across multiple domains, including mobility, physical function, frailty, and cognitive health,
focusing on cognitive decline and impairment and dementia. This proposed expansion will provide the
resources to support comprehensive studies of aging and aging biology in AsA and NHPI populations,
substantially increasing the scientific impact of the MOSAAIC cohort study. As part of the larger MOSAAIC
cohort, it will also serve as a valuable resource and platform for future ancillary studies, using stored
biospecimen and data to address emerging research questions beyond the scope of this application.

Public health relevance
Project Narrative Aging concerns of Asian American, Native Hawaiian and Pacific Islander backgrounds are poorly understood. We will expand the Multiethnic Observational Study in American Asian and Pacific Islander Communities (MOSAAIC) cohort to add 1,500 participants aged 65 and older and enhance our ability to study the mechanisms of aging in these groups.